Inflammatory Bowel Disease-Induced Inflammation Potentiates Atrial Fibrillation Risk

PROJECT ABSTRACT
Atrial fibrillation (AF) is the most common sustained arrhythmia that is estimated to affect over 40 million people
worldwide. Increases in atrial electrophysiological (action potential duration dispersion, altered conduction
velocity) and structural heterogeneity (fibrosis, scarring) can increase the risk for AF. The cause for AF is
unknown, but a variety of factors such as genetic predisposition, age, cardiovascular co-morbidities,
inflammatory diseases can increase its risk. Ulcerative colitis (UC), a subtype of inflammatory bowel disease,
was recently shown to increase a patient’s risk for AF. UC is an intestinal inflammation within the colon and
rectum of the gastrointestinal tract (GIT) that promotes gut dysbiosis. Patients with active colitis have a two-fold
increased risk for AF, and even in remission exhibit changes in atrial excitation and contraction that show atrial
remodeling. Yet, the mechanism with which UC increases the risk for AF remains undetermined and is the focus
of my project. Preliminary data in a mouse model of active colitis show an attenuated vagal tone, increased
sensitivity of the muscarinic acetylcholine receptor M2 (M2R) to cholinergic signaling, and prolonged atrial
conduction. These changes are reversible during remission, but in the chronic colitis model are maintained along
with a reduction in the heart/atrial weight, atrial myocyte size and electrophysiological and structural remodeling
of the atria. Based on my pilot data I propose to test the overall hypothesis that UC-induced dysregulation of
vagal nerve activity increases the risk for AF during UC disease progression. To test this hypothesis, I will use a
mouse model of active and chronic colitis. Aim 1 will examine the mechanism by which the risk for atrial
arrhythmic activity is increased during active colitis. In a mouse model of active colitis, I will determine if AF
occurrence is a consequence of a dysregulation in vagal signaling, promoting electrophysiological heterogeneity.
Aim 2 will determine the mechanism by which UC induces an exaggerated response of the heart to cholinergic
signaling. I will examine if a UC-induced attenuated vagal tone promotes an upregulation of atrial cardiomyocyte
M2R expression. Aim 3 will examine the mechanism by which the risk for atrial arrhythmic activity is increased
during chronic colitis. In a mouse model of chronic colitis, I will determine if AF occurrence is a consequence of
an increase in structural heterogeneity. The proposed work will elucidate a mechanism in which AF risk is
increased during UC disease progression. Successful completion of the proposed research would provide an
understanding of the interplay between the heart, GIT and ANS, and allow for a one possible mechanism of AF
to be determined. The findings will lay the groundwork for the creation of a translational treatment for one of the
diseases associated with UC. The research project will be guided by an exceptional team of sponsors that are
well-suited to provide the proper training of the techniques needed to complete the research, mentorship, and to
ensure short-term and long-term success of the trainee. The proposed work will also promote my ability to
execute a scientific project and development as an independent scientist.

Public health relevance
PROJECT NARRATIVE Ulcerative colitis (UC), a subtype of inflammatory bowel disease, is a chronic form of intestinal inflammation within the colon and rectum of the gastrointestinal tract where those affected exhibit local and systemic inflammation, gut dysbiosis, and extraintestinal manifestations such as changes (pathophysiological, electrophysiological) in cardiac function. During flare-ups UC patients exhibit twice the risk for developing atrial fibrillation (AF), the most common sustained arrhythmia worldwide caused by increased electrophysiological and structural heterogeneity. This project will examine the mechanism behind the increased risk for AF during UC disease progression.